NeuroFlex: Wireless, Mechanically Flexible, Stimulation-Capable Depth and Surface High-Density Microelectrode Arrays for Epilepsy

Project Summary/Abstract
Intracranial electrocorticography (ECoG) is widely used in the evaluation of patients with drug-resistant
epilepsy. Current neural interface technologies suffer from tradeoffs between the density of electrodes, ability to
sample from broad networks, and limitations on data transmission and power. Commercial subdural and
stereotactic depth electrode arrays used for continuous clinical monitoring require wired connections through the
skin to external electronics for days to weeks of in hospital monitoring. These arrays are costly to manufacture
or customize, cause significant brain tissue reactivity, and typically have small numbers (<64) of millimeter-scale
electrodes, significantly limiting recording resolution and detection of informative seizure features.
Here, we seek to translate to human use the NeuroFlex system of modular, fully implantable wireless depth
and subdural high density microelectrode arrays with support for up to 1024 recording and stimulating electrodes
on each implant. NeuroFlex builds on a custom complementary metal-oxide-semiconductor (CMOS) application-
specific integrated circuit (ASIC) developed under the DARPA Neuroelectronic Systems Design program that
provides wireless powering and high-throughput data telemetry as well as data conversion and front-end analog
electrical microstimulation and recording electronics in a fully implantable 1.2 cm × 1.2 cm chip, which is thinned
to less than 20 µm. Mechanically flexible, customizable polyimide extender depth or surface arrays are bonded
to each implanted circuit. Multiple arrays can be implanted with no wires or connections, and minimal volume
displacement. An external, wearable “relay station” powers and communicates with one or more arrays
indefinitely with no implanted batteries. Wireless operation mitigates several sources of patient risk and
discomfort and has the potential to untether patients from the hospital with ambulatory recording, while
dramatically improving the quantity and quality of data transmitted. The implants minimize tissue damage and
displaced volume, can be efficiently implanted and removed, and are inexpensive to manufacture and customize.
In the UG3 phase of the project, we will complete enhancements to the wearable relay station, surgical
implant technique, and data visualization software (Aim 1). In a porcine model, we will demonstrate recording
quality and stability for acute pharmacologically induced seizures and somatosensory evoked potentials, define
microstimulation parameters for cortico-cortical evoked potentials and electrocortical stimulation mapping, and
demonstrate safety. In Aim 3, we will perform additional biocompatibility, safety, and accelerate aging studies,
including prolonged device operation in a second animal model, and engage with the FDA for an Investigational
Device Exemption. In the UH3 phase, we will demonstrate feasibility of recording and stimulation for mapping
cortical function in human subjects in the intraoperative setting (Aim 4). After demonstrating initial human
translation, we will demonstrate safety, tolerability, and feasibility for fully-implanted, short-term (<30 days)
epilepsy intracranial monitoring (Aim 5). These studies are designed to bring the device to larger clinical trials.

Public health relevance
Project Narrative In this study, we will test the safety and efficacy of a modular system of fully implanted, wireless, high-channel- count surface and stereotactic depth electrode arrays for recording and stimulating the brain as the basis for a more patient-centered approach to diagnostic intracranial seizure monitoring and functional mapping for drug- resistant epilepsy. In the UG3 phase, the implants and wearable relay station will be optimized for clinical use and undergo benchtop and animal testing to assess feasibility, safety and biocompatibility in support of an Investigational Device Exemption. In the UH3 phase, we will demonstrate feasibility for cortical mapping in the intraoperative setting and for fully implanted, short-term (<30 days) epilepsy intracranial monitoring to inform necessary device modifications prior to larger clinical trials, device marketing, and possible therapeutic applications for epilepsy and other indications.